Empowerment-focused Outreach, Education and Enrollment of Tennessee Older Adults in the All of Us Research Program through Community Efforts by FiftyForward

The FiftyForward All of Us Program will address FiftyForward’s customer base and related individuals, including: o Members of our 7 FiftyForward lifelong learning centers o Customers of our Supportive Care Services programs, including: o Meals on Wheels o Adult Day Services o Victory Over Crime o Living at Home Care Management o Care Team and Conservatorship o FiftyForward volunteers o Foster Grandparent Program (FGP) o Retired Senior Volunteer Program (RSVP) o Friends Learning in Pairs (FLIP) o Children served by volunteer programs, and their family members o Family or friends of FiftyForward members or customers o Community members o Donors o Staff, Board, Advisory Board, and Committee Members o Health care professionals and other nonprofit organizations in partnership with FiftyForward